Chronic myosin activation as an agonist of cardiac mechanosensory pathways

PROJECT ABSTRACT
Heart failure with reduced ejection fraction (HFrEF) is a condition of decreased left ventricular contractility
affecting 32 million people worldwide, causing low exercise tolerance and eventually death. For nearly 40 years,
standard HFrEF care has primarily managed symptoms. Myosin activation is an emerging therapeutic strategy
that directly addresses the contractile deficiency. Unlike failed inotropic therapies targeting non-specific
adrenergic and calcium signaling, myosin activators bind directly to cardiac myosin to increase contraction.
Currently, danicamtiv, a next-generation myosin activator, is in clinical trials. My experiments and initial clinical
results indicate that danicamtiv improves upon the shortcomings of the first-generation activator, omecamtiv
mecarbil, which impaired diastolic function. Thus, myosin activation is poised to advance care for HFrEF patients.
Despite these promising results, the long-term effects of chronic myosin activation on the heart remain unknown.
This knowledge gap is significant for HFrEF patients who might use myosin activators for life. My preliminary
experiments show that 3 days of myosin activation elicits lasting cardiac effects after a 3-day washout period.
These include shorter isovolumic contraction time, increased left ventricular wall thickness, decreased left
ventricular diameter, and inverted ECG T-waves. This suggests that chronic myosin activation may stimulate
concentric hypertrophy. These persistent effects likely involve z-disk mechanosensation. The z-disk anchors
excitation-contraction coupling machinery and thin filaments in adjacent sarcomeres. It senses force through
stress-sensitive ion channels and protein complexes involving muscle LIM protein (MLP). Changes in force then
trigger cellular responses like hypertrophy via signaling proteins docked at the z-disk. Since the molecular effects
of myosin activation resembles some hypertrophic cardiomyopathy (HCM) myosin mutations, they may share
similar cardiac compensation mechanisms and long-term effects. While hypertrophy in HCM is highly
pathological, it may benefit HFrEF patients by counteracting left ventricular dilation and atrophy in end-stage
HFrEF. However, HFrEF pathophysiology may limit the heart's adaptation to chronic myosin activation due to
dysregulation of z-disk mechanosensation, excitation-contraction coupling, and metabolism. These lead to my
central hypothesis that chronic myosin activation elicits a hypertrophic-like cardiac response via z-disk
mechanosensation, but HFrEF pathophysiology will blunt this effect. Aim 1 will test if chronic myosin activation
with danicamtiv elicits a hypertrophic-like cardiac response. Aim 2 will utilize mice lacking MLP that develop
progressive HFrEF to test if disrupted z-disk mechanosensing and HFrEF pathophysiology blunt the response
to chronic myosin activation by danicamtiv. Successful completion of these experiments may identify a new
mechanism by which myosin activation improves HFrEF and inform how to best manage myosin activation
therapy in patients to maximize its effectiveness.

Public health relevance
PROJECT NARRATIVE Heart failure with reduced ejection fraction is a devastating condition with few effective treatments. Myosin activation is an emerging and promising therapeutic approach, but its long-term effects on the heart remain unknown. This information is critically important for managing patients who may be on myosin activation therapy for the rest of their lives; this project will study these long-term effects.